Antidementia medication use, safety, and effectiveness among nursing home residents with Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
This proposal is responsive to PA-17-088. The number of Americans living with Alzheimer’s disease is projected
to more than double from 5.6 million in 2019 to 13.8 million by 2050. This rise in Alzheimer’s disease prevalence
represents a serious public health concern. In 2019, Alzheimer’s disease was estimated to be the sixth leading
cause of death in the US and the fourth leading cause of disability adjusted life years lost. Half of the nursing
home population has a diagnosis of Alzheimer’s disease or another dementia. Only two available classes of
medications, cholinesterase inhibitors (ChEIs) and memantine have been demonstrated to slow symptomatic
progression of Alzheimer’s disease. Donepezil (the most widely used ChEI) has FDA indications for mild,
moderate, and severe Alzheimer’s disease, while memantine is indicated for moderate to severe Alzheimer’s
disease and has evidence supporting possible benefits in mild disease. Only ~40% of residents were treated
with either medication class at the time of nursing home admission historically (2006), and a small minority (10%)
received combination therapy. Nursing home residents may be at higher risk for adverse drug events from drug-
drug and drug-disease interactions due to a high burden of polypharmacy and comorbidities. Yet in the DOMINO
clinical trial conducted among community dwelling patients, discontinuation of a ChEI before the end stages of
the disease was associated with worse clinical outcomes. Nearly a quarter of nursing home residents treated
with ChEIs and/or memantine at the time of admission discontinued treatment shortly after admission (regardless
of dementia severity) and were potentially at risk for clinical worsening and the need to use more hazardous
drugs such as antipsychotics. Using contemporaneous, national, federally-mandated Minimum Data Set 3.0
linked to Medicare Part A and D claims, study aims are to: 1) examine contemporary patterns of ChEI,
memantine, and psychotropic medication use in NH residents with Alzheimer’s disease; 2) compare long-term
effectiveness, safety, and survival between residents initiating combination therapy, monotherapy, and no
treatment with ChEIs and memantine; and 3) identify resident characteristics (e.g., dosing, comorbid conditions,
concurrent medications, dementia stage) for whom treatment with ChEIs and/or memantine confers a net clinical
benefit. The proposed R01 is responsive to calls for well-designed long-term studies of ChEIs and memantine.
By expanding the evidence base to facilitate a dynamic resident-centered decision-making process regarding
Alzheimer’s disease treatment in an aged nursing home population, this proposal fulfills the goals of The National
Plan to Address Alzheimer’s Disease to effectively treat Alzheimer’s disease and to optimize care quality and
efficiency. This research is also closely aligned with the National Institute on Aging’s Strategic Goal to improve
the safe use of medications.

Public health relevance
PROJECT NARRATIVE Many older adults living in nursing homes have Alzheimer’s disease, which causes loss of cognitive and daily functioning. For most nursing home residents with Alzheimer’s disease, treatment with antidementia medication is recommended, but the majority of residents have not received treatment historically. This study will examine the use, safety, and effectiveness of antidementia medications for older nursing home residents with Alzheimer’s disease.